Creation and Repair of Postreplicative DNA Gaps

PROJECT SUMMARY/ABSTRACT
When a replication fork encounters a DNA lesion in a template strand, replication gives way to DNA repair
and recombination. These encounters define an interface in DNA metabolism that can give rise to genome
instability. This is ultimately manifested in tumor evolution in eukaryotes and the development of antibiotic
resistance and increased pathogenicity in bacteria. In this renewal application, we are investigating perhaps
the most enigmatic of repair processes, the repair of lesion-containing post-replication gaps. When a replisome
encounters a template lesion, disengages, and then re-initiates upstream, the lesion is left behind in a post-
replication gap. The existence of these gaps has been appreciated for over 5 decades, but progress has been
limited by methodology that has been inadequate to properly explore their general importance and repair.
These gaps are primary substrates for DNA synthesis by translesion DNA polymerases, recombinational DNA
repair, and replicational template switching, all processes linked with genomic instability.
Work in the last funding period has featured the development of a range of essential new methods, as
well as conceptual advances in our understanding of how post-replication gaps are generated and processed.
In E. coli, we now know that post-replication gaps are generated several times each replication cycle and that
gap formation is triggered by encounters with bulky nucleotide lesions. We have laid out the pathways by
which the gaps are targeted and resolved by particular DNA repair proteins. We are now in a position to
provide a deep molecular understanding of these pathways. As a bonus, we have identified four potential
bacterial vulnerabilities that may eventually provide pharmaceutical advances to treat antibiotic-resistand
pathogens or slow the development of antibiotic resistance.
We bring together world-class expertise in biochemistry, genetics, molecular biology, and biophysics.
We will apply our new methods, including novel single-molecule approaches, towards detecting and
quantifying gaps and further characterize the proteins acting on them. While driven by our mechanistic
questions, the new methods will broadly benefit research in genomic maintenance.
The six specific aims constitute a systematic attack on the problem. Aims 1-3 focus on the
recombinational DNA repair of post-replication gaps by the RecFOR system. Aim 4 is an exploration of the
single-stranded DNA binding protein (SSB) and how it directs the division of labor in gaps via its interactions
with 20 or more different repair proteins. Aim 5 focuses on the gap-related activation of the mutagenic DNA
polymerase V and its homologues, the source of most mutagenesis in any bacterial cell. Finally, aim 6
investigate an entirely new biological phenomenon, the presence of DNA sequence elements in the bacterial
genome that force the formation of post-replication gaps in particular locations.

Public health relevance
PROJECT NARRATIVE Genomic instability gives rise to aging, tumor evolution, DNA repeat expansion associated with multiple disease states, the development of antibiotic resistance in bacteria, and a general reduction in evolutionary fitness. This proposal addresses the molecular basis of an essential yet too often overlooked source of genomic instability, the repair of lesions in post-replication gaps that are left behind the replication fork. As gap repair is a primary source of mutagenesis and genomic rearrangements, we are proposing an integrated strategy to attain an in-depth understanding of gap formation and repair, aimed at providing new avenues to slow tumor growth and bacterial antibiotic resistance. Our project will address four separate vulnerabilities of bacterial pathogens that may eventually be used to address antiobiotic-resistand pathogens, one of them newly discovered.